Building Diversity in Biomedical Sciences

Tufts’ Building Diversity in Biomedical Sciences (BDBS) Program builds on a 30-year tradition of excellence in
preparing students from under-represented groups (URG) for careers in the biomedical workforce. BDBS has
an outstanding history of providing immersive summer research experiences in areas of NHLBI focus. Based
at Tufts University’s Graduate School of Biomedical Sciences (GSBS), BDBS has trained 220 students in the
past 15 years, all of whom have either completed or are still enrolled in undergraduate training. Among those
who have completed college, 129 have entered health-science-related graduate programs. Another 74 have
completed their degrees and 51 remain enrolled, while only four have left the programs without a degree. In
the coming period, we will build on this high record of success using insights from current education literature
on successful training approaches for URG students in the sciences, as well as formative and summative
evaluations and other surveys. Specifically, BDBS will build on the principle that independent research in an
inclusive welcoming community improves student self-confidence, persistence and success in a science major,
and overall interest in pursuing a research career. The core of our program is a rigorous and intensive 10-week
mentored summer lab experience focused on NHLBI research. A merger of Tufts Medical School with its major
clinical affiliate permits us to increase the number of preceptors – especially those in NHLBI research (from 40
to 52), and we provide them with culturally-aware mentor training. These preceptors are clustered into seven
areas of focus, such that trainees can further learn the value of interdisciplinary collaboration in small groups.
Their lab experience is complemented by Skills Workshops for training in scientific skills that enhance self-
confidence and identity as a scientist. Lunch with a Professor and Meet the Scientist introduce trainees to the
breadth of biomedical science careers and provide career models through interactions with faculty (beyond
their own preceptor), GSBS alumni who are biomedical leaders, BDBS alumni, graduate students, post-
baccalaureate, and postdoctoral scholars. BDBS trainees are housed together close to labs and public
transportation at the Tufts University Medical School residence, building their cohort community, while social
events that include GSBS students, faculty and alumni provide a diverse and welcoming community (25% of
our PhD students are from URG compared to 11% in 2018). A novel aspect of our social events are our
STEAM-based activities (STEM+Art to inspire our trainees to creative thinking), taking advantage of the Tufts
School of the Museum of Fine Arts and an outreach program for near-peer mentoring. By achieving our aims,
BDBS gives trainees the skills and confidence needed to persist and compete effectively for advanced training
positions, and eventually to assume leadership roles in the biomedical workforce. Our record demonstrates
that BDBS is making a strong contribution toward diversifying the biomedical workforce, and we anticipate that
our new approaches will build on this strong foundation to continue enhancing diversity in the biomedicine.

Public health relevance
Improving the health of all Americans, especially in the area of chronic diseases such as cardiovascular disease, pulmonary disorders and related conditions, relies on a strong diverse biomedical workforce that is prepared to address these health problems through basic and translational research. Our program trains talented undergraduates from groups underrepresented in biomedical science using a philosophy based on findings from educational scholarship and focused on health issues related to the NHLBI mission. We offer an intensive summer research experience supplemented with workshops in scientific skills, group activities that enhance self-actualization as scientists, career exploration and social events that encourage belonging, thereby preparing our trainees for advanced study in biomedical research.